The Microbiome-Gut-Brain Axis and Personalized Mediterranean Diet Interventions for Alzheimer's Dementia Prevention

PROJECT SUMMARY
The potential of the Mediterranean diet (MedDiet) in slowing cognitive decline and reducing Alzheimer's
dementia (AD) has been established through observational studies and the PREDIMED Trial. However, current
MedDiet recommendations were developed based on population averages and may not be best suited for a
given individual. Preliminary data from our group and others suggest that the individual response to MedDiet
may depend on the gut microbial profiles. Moreover, the gut microbiome, which communicates with the brain
along the "gut-brain axis," contributes to the development of AD. However, no randomized controlled trials
(RCTs) have examined the efficacy of personalized dietary approaches based on individual gut microbiomes
for AD prevention. Existing human microbiome studies on AD are often limited by cross-sectional designs,
small sample sizes, and a lack of high-resolution microbial profiling and longitudinal assessment of multiple
neuropathological processes. This background supports our central hypotheses that: 1) MedDiet contributes to
cognitive health partly through modulating the gut microbiome, and 2) the effects of MedDiet on cognitive
health vary by individuals’ gut microbial profiles. This project is highly responsive to PAR-22-093’s call for
“precision medicine for AD/ADRD by incorporating dense molecular endophenotyping” (NOT-AG-21-045). Our
proposal represents a highly cost-efficient study that leverages existing fecal and plasma samples, microbiome
data, and cognitive and brain MRI assessments from three well-conducted RCTs, PREDIMED-Plus (n=620),
DIRECT-PLUS (n=294), and MIND (n=604), as well as a prospective cohort study, Study of Latinos (SOL,
n=2,250). To gain deeper mechanistic insights, we will employ a multi-omics approach, combining whole-
genome shotgun metagenomics and metatranscriptomics to profile microbial composition and enzymatic
function and fecal and plasma metabolomics to measure the metabolic activity of the gut microbiome. Blood
and MRI imaging biomarkers will also be measured to delineate the multiple neuropathological processes
underlying AD development. We will investigate the roles of gut microbial composition and enzymatic function
in modulating the effects of MedDiet on cognitive changes (Aim 1), examine the interrelationships between
MedDiet, the metabolic activity of the gut microbiome, and cognitive changes (Aim 2), and investigate how
MedDiet-induced alterations in the gut microbiome influence the blood and imaging biomarkers of
neuropathological processes (Aim 3) in PREDIMED-Plus and DIRECT-PLUS. The findings from Aims 1, 2, and
3 will be validated and replicated in the MIND study, and their generalizability will be assessed in SOL. This
project will be the first to prospectively evaluate the role of the microbiome-gut-brain axis in primary AD
prevention in RCTs. It will generate personalized and translatable dietary interventions based on reproducible
biological mechanisms, contributing to the paradigm shift towards precision nutrition in AD prevention.

Public health relevance
PROJECT NARRATIVE The gut microbial community, in interaction with host dietary intakes, may play a significant role in the development of Alzheimer's dementia. Our proposed research aims to examine the contribution of gut microbes to the individual differences in the effects of the Mediterranean diet on age-related cognitive decline and the prevention of Alzheimer's dementia. By leveraging three well-conducted randomized controlled trials and a prospective cohort study, this project will establish fundamental insights into novel biological pathways, maximize the benefits of the Mediterranean diet, and ultimately develop more efficient and personalized dietary approaches to prevent Alzheimer's dementia effectively.